Interrogation of Non-Canonical Roles of VGSCs in Neurodevelopmental Epilepsy

PROJECT SUMMARY
Voltage-gated sodium channels (VGSCs) are transmembrane proteins with well-established roles
in neuronal physiology, including action potential initiation and propagation. Mutations in VGSCs
are associated with severe pediatric epilepsies. Despite the availability of VGSC-selective
pharmacotherapies, many patients do not achieve sufficient seizure control and no existing
treatment is effective for improving cognitive and behavioral impairments. Interestingly, VGSCs
are expressed early in the development of the nervous system before neurons are capable of
generating action potentials and before neuronal circuits have established. Certain variants in the
predominant developmental VGSC gene SCN3A are associated with severe cortical
malformations and Developmental and Epileptic Encephalopathy (DEE). Furthermore, studies of
VGSC functions in non-excitable cells have identified under-appreciated yet important functions
in a variety of cellular processes termed “non-canonical” functions, including regulation of Na+
homeostasis, inflammation, proliferation, and migration. Together these findings suggest that
VGSCs perform different roles in early development than in the mature brain. I hypothesize that
a greater understanding of these functions in VGSC-DEE will be important for developing effective
treatments. Here, I will use an innovative human induced pluripotent stem cell (hiPSC) derived
brain organoids carrying clinically relevant mutations in SCN3A and isogenic controls. Preliminary
studies have found irregularities in the patterning and morphology of SCN3A mutant cerebral
organoids and we have found that pharmacologic inhibition of VGSCs disrupts interneuron
migration in control hiPSC-derived cerebral organoids. While this data demonstrates
recapitulation of key clinical phenotypes in the cellular model, the mechanisms governing these
effects remains unclear. I propose to study non-canonical cellular functions in the following aims:
Aim 1 will examine the influence of SCN3A on cellular migration in the developing brain. Aim 2
will identify the molecular mechanisms by which SCN3A influences cellular processes of brain
development using single-cell RNA sequencing analysis to identify transcriptional differences
between control, SCN3A, and pharmacologically-treated organoids. Aim 3 will investigate the
therapeutic potential of corrective gene engineering. I will design and test a precise gene editing
approach to correct pathogenic SCN3A variants in human cerebral organoids. This proposed
project highlights the need for a paradigm-shift in thinking about the role of VGSCs in brain
development and new therapeutic strategies targeting diverse cellular functions of VGSCs.

Public health relevance
PROJECT NARRATIVE Voltage-gated sodium channels (VGSCs) mediate action potential propagation and transduction in neurons, however, recent work has shown that VGSCs serve additional functions in non- excitable cell types and in the developing nervous system. The potential contribution of these “non-canonical” functions of VGSCs to the development of neurodevelopmental conditions remains unknown. This proposed work will use human induced pluripotent stem cell-derived brain organoids and genome engineering to investigate the molecular mechanism underlying non-canonical VGSC contributions to neurological development and disease.